Analytical method validation to detect and quantify tulathromycin residues in caprine liver

PROJECT SUMMARY
This project aims to address the significant problem of bacterial pneumonia in goats,
which is a major cause of morbidity and mortality and represents a significant welfare
challenge for operations in the United States. Currently, there is only one FDA-approved
antibiotic for the treatment of respiratory disease in goats, which requires daily
administration. That decreases efficacy in situations where owner compliance with
labeled instructions is lacking. To address this problem, the proposed research aims to
validate an analytical method for the detection and quantification of tulathromycin
residues in caprine liver and conduct a freezer stability study of tulathromycin in caprine
liver. The expected outcome is to have a validated LC-MS analytical method for the
detection and quantification of tulathromycin residues in caprine liver that will be used
for completion of the HFS technical section and future studies to determine
tulathromycin residue depletion. The label approval of Draxxin® 25 will make it easier
for veterinarians to use tulathromycin in goats with confidence in scientifically based
labeled slaughter withdrawal times.

Public health relevance
PROJECT NARRATIVE In contrast to major food-producing species such as cattle and swine, for which many antimicrobials are labeled for treatment of respiratory disease, there is currently only a single antibiotic (ceftiofur) approved by the FDA for treatment of respiratory disease in goats. Ceftiofur sodium requires daily administration which may decrease efficacy in situations where owner compliance with labeled instructions is lacking. Therefore, there is an urgent need for additional FDA-approved products for treatment of respiratory disease in goats.